SAIA-PrEP: a systems analysis and improvement approach to optimize PrEP implementation in syringe service programs

ABSTRACT
For the first time in decades, HIV incidence is increasing among people who inject drugs (PWID). Pre-
exposure prophylaxis (PrEP) is a safe, effective, evidence-based HIV prevention strategy recommended for at-
risk PWID. However, despite the acceptability of PrEP among PWID, access remains low, and uptake has
lagged far behind that observed in other vulnerable populations. Our preliminary research demonstrates that
syringe service programs (SSPs) are uniquely poised to improve PrEP access, and many already provide
some services along the PrEP delivery cascade, including PrEP education, HIV testing, and linkage to onsite
and external medical services. Despite being ideal venues for improving PrEP access among PWID, our data
demonstrate that these agencies need additional support to optimally implement the SSP-based PrEP delivery
cascade. This novel randomized controlled trial (RCT) uses an interrupted time series design to test whether
an evidence-based, organization-level intervention, the Systems Analysis and Improvement Approach (SAIA),
can improve the delivery of PrEP services among 32 SSPs located in Ending the HIV Epidemic priority
jurisdictions. After a 3-month run-in period, SSPs will be randomized to receive SAIA (n=16) versus treatment
as usual (n=16). SAIA will be delivered by trained specialists through five cyclical steps over 12 months: (1)
analyze SSPs’ PrEP delivery cascade to identify priority areas for system improvements, (2) map processes
and build consensus around programmatic modifications to address priority areas, (3) implement programmatic
modifications, (4) assess effects of programmatic modifications on delivery of cascade services, and (5) repeat
steps 1-4 as needed. SSPs will use an electronic data collection system to report on outcomes including
numbers of SSP clients receiving (1) PrEP education, (2) HIV testing, (3) PrEP linkage, and (4) PrEP initiation
verification. Data will be collected during the 3-month run-in period prior to randomization, and then for an
additional 24 months, allowing us to identify initial impacts of SAIA after 12 months (Aim 1) and sustained
impacts at 24 months (Aim 2). Outcomes will be disaggregated by sex and race/ethnicity to allow for process
monitoring of programmatic changes to address equity in service delivery. We will also estimate the cost and
cost-effectiveness of SAIA relative to treatment as usual using an activity-based costing approach (Aim 3). To
our knowledge, this will be the first RCT of an organizational-level intervention to optimize the SSP-based
PrEP delivery cascade. If successful, SAIA could be disseminated to the ≥430 SSPs nationally and in global
settings, carrying the potential for exceptional impact amidst persistent HIV transmission in PWID.

Public health relevance
PROJECT NARRATIVE Delivering antiretroviral pre-exposure prophylaxis (PrEP) to people who inject drugs (PWID) through syringe services programs (SSPs), a trusted and well-utilized institution, is acceptable and feasible, yet interventions are needed to support and scale-up the implementation of these services. This randomized controlled trial will assess the effectiveness and cost-effectiveness of an organization-level intervention designed to help SSPs optimize the delivery of PrEP services for PWID.